Role of the environmental sensor, AhR on colitis

The environmental sensor, aryl hydrocarbon receptor (AhR) serves as a ligand for pollutants as well as
for plant, microbial and endogenous compounds. Following AhR ligation, the activated AhR regulates gene
expression through the binding of AhR/ARNT complex to specific DNA motifs known as Dioxin Response
Elements (DREs). Studies from our lab and elsewhere have shown that some AhR ligands have potent
immunosuppressive properties. Inflammatory bowel disease (IBD) results from chronic inflammation in the
gastrointestinal tract that affects 1.5 million people in the US. The pathogenesis of IBD involves complex
interactions between gut microbiota, immune response, environmental and dietary factors, and
genetic/epigenetic regulation. Recently, we made an exciting observation that the AhR ligand and plant product,
I3C ameliorates colitis in mice, which was associated with anti-inflammatory effects, regulation of gut dysbiosis,
and enhanced expression of β-defensins (mBD1,2,3) by Colonic Epithelial Cells (CEC). β-defensins constitute
antimicrobial peptides (AMPs) that resist microbial colonization of epithelial surfaces in the colonic tissue. β-
defensins may also mediate anti-inflammatory effects. In fact, studies have shown defective expression of
intestinal AMPs particularly defensins in IBD patients. We were excited to uncover DREs in the promoters of
mouse β-defensins (mBD1, 2, and 3). In the current study, we will test the central hypothesis that dietary indoles
(I3C) attenuate colitis through AhR activation leading to increased expression of mBDs by CECs via pathways
involving DREs, and/or epigenetic regulation resulting in modulation of microbiota and prevention of epithelial
barrier damage. Furthermore, we propose that mBDs induced by I3C play a critical role in restoring healthy gut
microbiota, preventing intestinal barrier damage and suppressing colonic inflammation through induction of
Tregs. Aim 1 will test the mechanisms of mBD induction by dietary indoles. We will use reporter assay, promoter
bashing and electrophoretic mobility shift assay to determine whether I3C activated AhR directly binds to the
DREs to induce mBDs. We will also determine the effect of I3C on the mBD expression by using AhR cKO mice
with AhR deletion in IEC, ILC3 and Tregs. In Aim 2, we will study epigenetic regulation of β-defensins by dietary
indoles. To that end, we will test whether I3C regulates mBD expression by altering histone modification and
decreasing DNA methylation. We will specifically determine if I3C regulates the SATB1-mediated histone
deacetylation and chromatin remodeling. In Aim 3, we will test whether administration of mBDs offers protection
from colitis by regulating gut dysbiosis, preventing CEC barrier damage, enhancing Treg subsets and decreasing
Th17 subpopulations to attenuate colonic inflammation. Finally, we will use mBD KO mice to test whether mBDs
are required for I3C-mediated protection from colitis. The proposed studies are highly significant because they
will identify novel mechanisms through which dietary indoles suppress colitis by altering the microbiota, through
activation of AhR leading to increased expression of host-derived AMPs, specifically β-defensins.

Public health relevance
Environmental pollutants as well as plant, microbial and host-derived products can bind to aryl hydrocarbon receptors (AhR). Our studies will determine how dietary indoles bind to AhR and then elements in the DNA to produce anti-microbial peptides. These peptides can cause changes in gut microbiota and immunosuppression.